Achieving Sustained Control of Inflammation to Prevent Post-Traumatic Osteoarthritis (PTOA)

Knee Osteoarthritis (KOA) is highly prevalent in U.S. military service members and Veterans due to the impact
of joint trauma and overuse injury. Its socioeconomic impact is estimated at $60 billion per year, and no
disease-modifying treatments exist. Joint inflammation is linked to severity and progression of disease 4, but
current anti-inflammatory medications do not protect against progression, and have substantial side effects.
The purpose of this project is to develop and employ a novel method to modulate the local inflammatory
response in the joint after an injury in a sustained manner, to prevent post-traumatic osteoarthritis (PTOA).
Specifically, we hypothesize that modulation of Toll-like receptor (TLR) activation, via blockade of the
TLR co-receptor CD14, will reduce development of PTOA pathology and functional decline after knee
injury. We were the first to discover high levels of CD14 in OA patients and show that it augmented TLR-
mediated inflammatory responses. We have now demonstrated that genetic deficiency of CD14 reduces signs
of disability and prevents progression of cartilage damage in a murine model of PTOA; Our preliminary data in
this same model shows that pharmacologic blockade for therapeutic purposes is possible. We propose to
establish blockade of TLR co-receptor CD14 as an effective strategy to prevent PTOA pathology and functional
decline, using a large-animal (mini-pig) model of knee OA developed by our team. We will optimize intra-
articular (IA) delivery of a clinically developed CD14 blocking antibody to achieve sustained release during the
post-injury period, by encapsulating the antibody in innovative Mechanically Activated Microcapsules
(MAMCs). Finally, we will test whether TLR activation markers in Veterans with KOA can predict clinical
response to an existing anti-inflammatory therapeutic, with a focus on functional recovery, in order to optimize
patient stratification for future clinical trials of TLR-targeted anti-inflammatory therapies.
In Aim 1, Yucatan mini-pigs will undergo bilateral arthroscopic destabilization of the medial meniscus (DMM)
surgery of both hind limbs. Starting one week after surgery, a neutralizing anti-CD14 monoclonal antibody
(Implicit Biosciences) will be delivered IA to one knee; the contra-lateral side will receive isotype-matched
antibody control. Functional outcomes will include activity and knee joint flexion angles measured every two
weeks using a wearable motion-sensor device. Synovial fluid (SF) and serum will be collected prior to DMM
and at endpoints for molecular/cellular analysis of effects of treatment. Groups of animals will be euthanized at
endpoints up to six months after surgery, and PTOA pathology evaluated using novel MR imaging techniques
allowing clinically-relevant early cartilage molecular changes to be detected, and imaging data will be validated
using standardized histopathology. In Aim 2 we will optimize encapsulation of anti-CD14 in MAMCs using
microfluidic double emulsion technology, and confirm sustained delivery of active drug after encapsulation
using in vitro and ex vivo analyses. Encapsulated anti-CD14 will then be delivered IA to one hind knee joint of
DMM-operated mini-pigs, and encapsulated control antibody to the contra-lateral side. A single dose will be
given one week after DMM. The effects of encapsulated anti-CD14 vs. unencapsulated anti-CD14 on
pathology and functional outcomes will be compared. Retention and distribution of MAMCs in the joint will be
assessed by IVIS imaging. Finally, in Aim 3, we will leverage the availability of SF samples from participants in
a VA-funded clinical trial (MOVE-OK study) testing the efficacy of IA corticosteroids in Veterans with knee OA.
Biomarkers related to TLR activity (including sCD14, sTLR4, LBP) will be measured in SF collected and stored
as part of the MOVE-OK protocol, using ELISA/multiplex assays. Associations between biomarker levels, and
change in activity levels and disability scores with therapy will be tested using linear regression analysis.
Pursuit of this project will result in the development of an innovative method to control joint inflammation after
injury, and inform patient selection for future clinical trials of TLR-targeted immunomodulatory approaches.

Public health relevance
This work will benefit both Veterans and civilians who have osteoarthritis, by developing a novel approach to reduce harmful inflammation in the joint after an injury, and prevent the onset of post-traumatic osteoarthritis and associated disability. The number of patients in the US estimated to have symptomatic osteoarthritis approaches 27 million. Incidence rate is 26% higher in active duty service members 20-24 years old, and >100% higher for those >40 years old, than the general population. This is largely due to increased incidence of acute and chronic joint injury in the military. This project will identify a novel method of treatment to inhibit inflammation that contributes to arthritis development and joint dysfunction after joint injury. Expanding medical approaches for OA and joint injuries will improve quality of life, enhance rehabilitative efforts, and diminish the need for joint replacement in Veterans.